Proteomics Laboratory Shared Resources

Abstract/Project Summary
PROTEOMICS RESOURCE LABORATORY SHARED RESOURCE (PRL)
The Proteomics Resource Laboratory (PRL) provides support for mass spectrometry-based
proteomics analysis for all Perlmutter Cancer Center (PCC) investigators through a centralized
facility, with state-of-the-art instrumentation and highly specialized technical expertise. Under
the direction of Dr. Beatrix Ueberheide, a well-established expert in biological mass
spectromety, PRL was established 5 years ago to expand upon the successful Proteomics
Core. PRL aids scientific discovery at PCC by providing access to specialized expertise and
state-of-the-art instrumentation for the analysis of proteins and peptides using mass
spectrometry (MS). A special focus of the laboratory is assistance with experimental design and
full support for downstream data analysis, often involving innovative data analysis pipelines.
Significant economies of scale are achieved by this centralization of resources. PRL achieves
its mission via four Specific Aims: Aim 1) To provide mass spectrometry-based, state-of-the-art
proteomics technologies to PCC investigators and full downstream data analysis support; Aim
2) To provide highly customized support tailored to specific projects and research questions of
PCC investigators; Aim 3) To develop and implement novel techniques to ensure continued
support of state-of-the-art proteomics technology for PCC investigators; Aim 4) To provide
education to graduate students and post-doctoral researchers on proteomics techniques
through graduate teaching and close collaboration with PCC investigators.